Core A: Administrative Core

Excellent organization and communication will be the keys to our success. Both will be the responsibility of the Administrative Core. Core personnel will achieve these goals by:1) maintaining a centralized location for the accumulated grants information and research publications;2) providing efficient dissemination of information to the project and core leaders;3) arranging several key conferences and meetings which will provide oversight and planning of the research activities. RELEVANCE (See instructions): The Administrative Core is necessary to coordinate the activities of the Center.